CTSA K12 Program at The Ohio State University

Abstract:
The overarching goal of the Ohio State University (OSU) Center for Clinical and Translational Science affiliated
K12 program is to develop a cadre of well-trained, diverse, early-stage faculty investigators through
individualized training to engage fully, succeed, and lead in clinical translational research and science
(CTR/CTS). The program is open to eligible early career faculty members at the Ohio State University (OSU)
and Nationwide Children’s Hospital (NCH). To accomplish this, we propose the following Specific Objectives
(S.O.): S.O.1) Provide training to foster the development and long-term success of diverse, early career faculty
engaged in clinical and translational research; S.O.2) Provide mentorship training and monitor progress for
scholars, mentors, and mentor-mentee dyads; S.O.3). Support the development of skills for scholars to lead in
translational science; and S.O.4) Conduct ongoing evaluation of program and scholar outcomes for continuous
improvement. Highlights of our comprehensive, impactful, and innovative programmatic training elements
include: development of monitored individual training plans (IDP); structured communication and grant writing
preparation; leadership skill development; understanding and thriving in a team science environment; training in
responsible conduct of research; training in research ethics; training to promote diversity and inclusiveness in
research teams and participants; research design and data interpretation; and training in rigor and reproducibility
in the conduct of research. Program elements will be opened to other institutional and individual K scholars at
OSU and NCH. Training in Diversity, Equity, Inclusion and Accessibility is provided to both K12 mentors and
mentors. Four early career K12 scholars will be trained with two-year appointments (2 per year) supported by
the K12, followed by institutional support to continue a third year of K12 training. Scholar success will be defined
based on research productivity (particularly independent research funding in CTR/CTS) and progression in the
characteristics of a translational scientist. Scholars will be monitored during the K12 based on their IDPs with a
dedicated team of senior mentors engaged and funded in CTR/CTS and experienced in mentoring early-stage
faculty. The K12 Program will regularly track progress of of its Specific Objective by evaluating career
advancement as CTR/CTS scientists (independent research funding, publications, academic promotion) and
participation and leadership in clinical and translational research and clinical and translational science. A RE-
AIM and Logic Model framework will be used for programmatic evaluation and programmatic adaptation. The
OSU campus research environment with our urban, suburban, and rural patient communities, and the ability to
look at questions across the lifespan through our partnership with NCH provides a range of opportunities to train
future leaders in clinical and translational research and science.

Public health relevance
Project Narrative: This institutional training grant will train early career faculty at the Ohio State University and Nationwide Children’s Hospital. The goal is to develop individualized plans and comprehensively train faculty to participate in and then lead in clinical and translational research, to ultimately improve human health for all.